Strengthening a Brief Intervention for Justice-Involved Substance Users by Harnessing Mechanisms of Change

Project Summary/Abstract.
Substance use among justice-involved individuals constitutes a public health problem that is linked to negative
consequences for offenders, their families, and their communities. As criminal justice reform becomes a reality
in the United States and more justice-involved substance users join the general population, there is reason for
therapeutic optimism. Our preliminary work shows that measuring heterogeneity in psychopathic personality
traits can guide the use of a brief substance use intervention to people who will benefit. Our innovative
assessment and matching-to-treatment approach has promise for a) revealing the true efficacy of a brief
motivational intervention (BMI) for justice-involved substance users at varying levels of psychopathic traits,
and b) explaining contradictions in the BMI literature. Additionally, the current proposal is a Phase III
randomized clinical trial in which we will use rigorous multi-method assessment to test two putative
mechanisms of change: commitment to change and self-regulation. By elucidating the mechanisms through
which justice-involved substance users' change in treatment, we will make adaptations that further strengthen
our intervention and increase the range of people who benefit. Hypotheses that will be examined include: 1)
that a BMI, adapted for use in criminal justice supervisory settings, will reduce substance use relative to
Standard Care for individuals with low/moderate affective traits of psychopathy, 2) that the reduction in
substance use will be mediated by commitment to change and an increase in self-regulation, enabling
adaptations that target these processes and lead to a better intervention, and 3) that the moderated reduction
in substance use will mediate a reduction in violent recidivism at follow-up.

Public health relevance
Project Narrative. Brief motivational interventions for substance use are used in criminal justice systems across the country. The present research is designed to determine for whom and by what mechanisms these interventions work and whether they reduce violent recidivism.